Characterizing the IgG1 Memory B cells that are precursors of pathogenic IgE

PROJECT SUMMARY:
IgE-mediated food allergy affects approximately 1 in 13 children in the USA and has continued to grow in
prevalence in recent decades. For many, current immunotherapies are ineffective, making this is a lifelong
disease with significant impairment in quality of life. Although IgE is central to the pathophysiology of food
allergy, the mechanisms maintaining high affinity (pathogenic) IgE are not well understood. Previous work
from our laboratory has shown that IgE memory in mice is contained within a population of antigen-specific
IgG memory B cells (MBC) that can undergo class switching to IgE. However, strategies targeting a broad
subset of IgG-expressing cells for treatment of food allergy is complicated by the need to retain protective
immunity against pathogens. Therefore, it is important to identify the specific IgG MBC that have the ability
to generate high affinity IgE responses. This proposal seeks to use mouse models of peanut allergy to
identify immunophenotypic markers that can distinguish IgG MBC subsets with the ability to produce high
affinity IgE plasma cells (PC). In addition, this application will address the plasticity of this cell fate and the
external signals that are required for IgG MBC differentiation into IgE PC. Ultimately, we want to
understand what it takes for an IgG MBC to become a pathogenic-IgE producing plasma cell and reveal
targets that could be amenable to therapeutic intervention to improve the quality of life of patients who
suffer from food allergies.

Public health relevance
PROJECT NARRATIVE: IgE-mediated food allergy is a growing public health concern. Allergen-specific IgE is largely responsible for the clinical manifestations of allergic reactions, such as life-threatening anaphylaxis. The affinity of the IgE plays a major role in determining the outcome of a patient after exposure to food allergen. IgE that is of high affinity can trigger anaphylaxis, while IgE of low affinity poses little risk and may even be preventative. It is well understood that IgG memory B cells can differentiate into IgE producing plasma cells; however, not enough is known on the distinct pathways involved to form high affinity, rather than low affinity IgE, have not been described. This proposal seeks to understand the intrinsic characteristics and/or external cues that regulate memory B cell differentiation into IgE plasma cells. We expect that outcomes of this work will identify immunotherapeutic approaches for the treatment of food allergy.